METABOLIC STUDIES IN TUMORS WITH L-(13N) AMINO ACIDS

The objectives of the proposed research are to contribute to the management of cancer patients by using nitrogren-13 labeled amino acids as imaging agents for assessment of tumor function and functional response to therapy and to obtain a better understanding of in vivo tumor metabolism by study of N-13 L- amino acids. We shall study the selectivity of in vivo concentration of N-13 derived for intravenously administered L(n-13) tyrosine in human tumors with aberrant aromatic amino acid metabolism such as malignant melanoma and neuroblastoma by scintigraphic measurements. The specificity of label accumulation from tyrosine will be determined by sequential studies with L-(N-13) glutamate. L-(amideN-13) Glutamine will be evaluated in comparison with L-(N-13) glutamate for scintigraphic measurement of soft tissue sarcoma tumor response to therapy in paired, same session studies. The efficacy of L-(amide-N-13) glutamine as an imaging agent of detecting extrahepatic colorectal metastases shall be determined. The mechanisms of localization and the metabolic fate of the labeled amino acid shall be studied in transplanted rodent tumors as a means of interpreting cancer in humans. The animal studies will employ imaging procedures as well as dissection of tumors and analyses of extracts utilizing high performance liquid chromatography and analyses of extracts utilizing high performance liquid chromatography and analyses of radioactive peaks by chemical and enzymatic techiques. Concurrent studies will be carried out with N-13 and C-14 labeled L-glutamine and glutamate to study the fate of the carbon skeleton of the amino acids and to determine its role as an energy source for tumors.